Synaptic Circuitry in Stroke

Spreading depolarizations (SDs) that occur in stroke and traumatic brain injury patients exacerbate the neuronal
damage in metabolically compromised tissue. SDs are waves of sustained neuronal and glial depolarization that
actively propagate a breakdown of ion gradients through the injured brain. The ion fluxes during SD are followed
by a rapid accumulation of water inside neurons and astrocytes causing cytotoxic edema. Pyramidal neurons
lack functional aquaporins. This implies that passive osmotically obligated water entry after the ionic movements
during SD is unlikely. Using pharmacological inhibition, we have identified several chloride-coupled
cotransporters that mediate ion and water fluxes and can participate in neuronal swelling. Recently mice with
conditional deletion of these transporter proteins were generated offering unique opportunity to identify the exact
molecular conduits of water influx into neurons during SD, and this will be studied in Aim 1. Cytotoxic edema
distorts intracellular organelles. Mitochondria play a variety of functional roles in neurons, from metabolic support
and neuroprotection to the release of cytokines that trigger apoptosis. In dendrites, the mitochondrial structure
is closely linked to their function, and fragmentation of the normally elongated mitochondria indicates loss of their
function under pathological conditions. To date, fragmentation of mitochondria was studied either in dissociated
cultured neurons or brain slices, but not in the intact living brain. Using real-time in vivo 2-photon microscopy,
we quantified mitochondrial fragmentation during brain injury. We demonstrated that alterations in neuronal
mitochondria morphology occurs within minutes of injury onset and can be reversible in traumatic and ischemic
injuries. Impact of SD on mitochondrial structure could be one of the major factors affecting mitochondrial
fragmentation and neuronal survival during noxious conditions, and it will be examined in aims 2 and 3. The
specific aims are: 1) To identify neuronal chloride cotransporters that are involved in the onset of SD-induced
neuronal swelling. 2) To test the hypothesis that SD is the triggering mechanism of rapid neuronal mitochondrial
fragmentation. 3) To test possible mechanistic links between SD and mitochondrial fragmentation. The proposal
integrates a variety of classic and state of the art technologies; viral expression, mouse genetics, in vivo 2-photon
microscopy coupled with electrophysiology and laser speckle imaging, as well as ultrastructural analyses with
serial section transmission electron microscopy. A novel automatic analysis algorithm, based on supervised
statistical computer learning will be used to quantify the degree of dendritic mitochondrial fragmentation. Model
of transient global ischemia (BCCAO) will be used to evoke SD. In a model of focal stroke (photothrombotic
occlusion) and the healthy cortex, SD will be evoked by KCl microinjection. The results will bring new insight into
the development of cytotoxic edema during the stroke injury. The experiments will also address how and under
what conditions the mitochondrial organelles are affected by SD and reveal mechanistic links between SD and
mitochondrial fragmentation.

Public health relevance
Project Narrative Neurologic emergencies such as ischemic and hemorrhagic stroke, head trauma, cardiac arrest, and asphyxiation-hypoxia are the top causes of mortality globally. Two of the major pathogenic events that cause acute brain damage during these clinical conditions are the spreading depolarizing waves and the associated brain swelling that course across the cortex injuring brain cells. Detailed understanding of how this injury evolves will help to design treatments for brain recovery in these neurologic conditions.